Facing Eating Disorder Fears for Anorexia Nervosa: A Virtual Relapse Prevention Program Targeted at Approach and Avoidance Behaviors

PROJECT SUMMARY/ABSTRACT
Anorexia nervosa (AN) is chronic and disabling; most individuals never achieve full remission,
even after acute treatment, and 50% of those who access acute treatment will relapse within 6-
months of discharge. AN relapse-prevention treatments are urgently needed that can disrupt the
persistent cycle of admission and discharge from acute treatment. Importantly, existing
treatments do not differ from control treatments in the ability to alter cognitive-behavioral AN
pathology, which is the primary remaining symptomatology at discharge from acute care. The
inability to alter cognitive-behavioral pathology is a function of the limited availability of
treatments that include skills training to promote behavior change in a “real-world” context,
outside of treatment facilities. As such, relapse-prevention treatments should explicitly target
core cognitive-behavioral pathology to facilitate approach behaviors (e.g., facing fear foods) in
the real-world. Our scientific premise, developed from our past work, is that the application of a
virtual format of Facing Eating Disorder Fears (FED-F) for AN will facilitate engagement in
approach behaviors and minimize avoidance behaviors - improving outcomes, enhancing full
recovery, and decreasing the likelihood of relapse. FED-F is a modular treatment that enhances
exposure therapy with psychoeducation and cognitive skills teaching how to face fears of (a)
food, (b) weight gain, (c) interoception/body, and (d) social situations. Our study goals are to (1)
refine and test the acceptability and feasibility of FED-F delivered post-acute treatment as
adjunctive to step-down specialty care, (2) test if this treatment outperforms treatment as usual
(TAU), and (3) to examine if treatment targets our hypothesized mechanism of action: approach
behaviors. These goals will lead to a highly deployable and accessible virtual treatment targeted
at core AN mechanisms that predict relapse. The proposed research uses highly innovative
methods; we will use an all-remote technology-based approach, combining a virtual, non-
therapist assisted treatment with remote behavioral and momentary assessment of
approach/avoidance behaviors. Specific aims are to (1) refine FED-F into a fully virtual format
with input from patients and stakeholders and collect preliminary data (N=10) on its feasibility
and acceptability, (2) conduct a small pilot RCT of FED-F (n=30) as compared to TAU (n=30),
and (3) examine if FED-F targets approach/avoidance behaviors and test if this mechanism is
associated with clinical outcomes. Ultimately, this proposal will lead to the creation and
dissemination of a highly user-friendly, easily accessible and deployable intervention, delivered
during a critical period of care, that can prevent AN relapse, which will decrease mortality,
morbidity, and the high costs associated with chronic treatment.

Public health relevance
PROJECT NARRATIVE This project will refine the Facing Eating Disorder Fears (FED-F) for anorexia nervosa (AN) relapse-prevention treatment designed to prevent relapse after discharge from acute treatment. We will assess the feasibility, acceptability, clinical efficacy, and target engagement of this treatment versus treatment as usual. The proposed research has significant public health relevance, as it will directly lead to a highly accessible and deployable treatment that can decrease AN relapse and the high societal burden associated with AN. The proposed research is relevant to NIH’s strategic aim 4.3 as it will lead to the creation of an innovative evidence- based service delivery model using technology that can be easily disseminated to communities in need during a critical period of transition of care.